Leveraging Zika virus driven myeloid cell responses to treat GBM

PROJECT SUMMARY
“Leveraging Zika virus-driven myeloid cell responses to treat GBM”
Oncolytic viral therapy shows promise for high-grade solid tumors, but none have been shown to provide
curative potential. This study explores the potential of harnessing the natural tropism of Zika virus (ZIKV) to
target glioblastoma stem cells (GSCs) and reprogram the typically immune suppressive GBM tumor environment
to an inflammatory, antigen-presenting environment that induces GBM-specific CD8+ T cell responses. The first
goal of this proposal is to identify the cellular mechanisms that drive anti-tumor T cell responses following ZIKV
treatment. Our research will examine the functional roles of two distinct myeloid cell subsets induced following
ZIKV treatment - CCR2+ monocytes in the tumor microenvironment (TME) and dendritic cell subset-2 (DC-2s) in
draining lymph nodes (dLN) - in driving anti-tumor T cell responses against GBM. Additionally, our study will
examine the synergistic therapeutic potential of a highly novel Flt3 ligand therapy and ZIKV combination therapy
as a strategy to activate both dendritic cell subset-1 (DC-1s) and DC-2, to maximize anti-tumor CD8+ T cell
responses and subsequent GBM rejection. This research is significant because 1) it addresses the potential of
ZIKV as an effective oncolytic virus for GBM treatment, 2) identifies key cellular mechanisms that contribute to
its anti-tumor effects and 3) addresses the current failure of immunotherapy and maps a therapeutic path forward.